SIGNALS THAT PATTERN THE ANTERIOR CENTRAL NERVOUS SYSTEM

Previous studies implicate members of the Hedgehog (Hh) and Nodal signaling pathways in specification of the anterior central nervous system (CNS). The proposed studies are based on a specific hypothesis that postulates that Nodal and Hh signaling systems interact in a network. Experiments will test this hypothesis by analyzing loss and gain of function of components in both the Nodal and Hh pathways and by identifying the regulators of these pathways in a forward genetics mutagenesis screen.